Mining the North American Mitochondrial Disease Consortium (NAMDC) Clinical Registry Data to Identify Phenotypes and Outcome Measures for Mitochondrial Diseases

Project Summary/Abstract This application seeks funding to support mining of the NAMDC Clinical Registry to: 1) better characterize the phenotypes of several of the more frequent mitochondrial disease syndrome and causative mutations; 2) define potential outcome measures for future natural history and clinical trials; and 3) identify correlations among phenotypic manifestations and phenotypic domains.

Public health relevance
Because the field of mitochondrial disease research is still young and the spectrum of mitochondrial diseases still being defined, it is critical to undertake fundamental analyses of clinical phenotypes and genotypes of patients. Current portrayals are based on limited data. The NAMDC Clinical Registry contains a wealth of patient data including longitudinal information about disease progression that has not yet been analyzed in depth. It is therefore critical to perform deeper phenotypic analyses of the NAMDC Clinical Registry to define mitochondrial disorders. In this project, we propose to provide financial support (and incentive) to complete essential data analyses and draft a series of manuscripts on specific, frequent mitochondrial disease syndromes, molecular genetic defects, and organ involvement. These analyses are not merely descriptive studies, but rather critical for defining the most important clinical features for natural history studies and ultimately clinical trial outcome measures.